The role of comprehensive adult Medicaid dental benefit in improving oral health and reducing disparities among adults and children

The Role of Comprehensive Adult Medicaid Dental Benefit in Improving Oral Health and Reducing
Disparities among Adults and Children
Project Summary
Even though it is well established that oral health is integral to overall health, economic productivity, and well-
being, it remains the most common unmet health need in the US. Low-income and minority groups carry a
significantly high burden of dental disease, highlighting socioeconomic disparities and lack of access to oral
health care. A large proportion of these groups rely on Medicaid, but unlike children, federal law does not
mandate dental coverage for adults, and coverage varies by state leaving many uninsured or underinsured.
Starting July 2021, Virginia expanded dental coverage for all Medicaid-enrolled adults (up to 138% of FPL),
providing access to comprehensive dental care to thousands of adults for the first time. This dental policy
change provides a unique opportunity, a 'natural experiment,' to gain a deeper and clear understanding of the
effect of implementing a comprehensive dental benefit on the oral health of Medicaid enrollees and fill a critical
gap in oral health services research. The purpose of the proposed K08 research project is to evaluate the role
of Virginia's comprehensive adult Medicaid dental policy on dental care utilization and reducing oral health
disparities among the Medicaid population. The project will: 1) examine the demand for dental services among
Medicaid-enrolled adults following the implementation of the dental benefit, 2) evaluate the impact of dental
benefit on the use of the emergency department (ED) for dental visits by comparing adults enrolled in Medicaid
with those having private insurance, and 3) assess the effect of the Medicaid adult dental benefit on children's
dental care use. Data sources will include multi-year claims data from the Virginia Medicaid program and
Virginia All Payers Claims Data that will be linked with the county-level workforce and community data on
social factors from multiple sources. Causal inference methods and advanced econometric and data science
approaches such as difference-in-difference and interrupted time series will be used to isolate the policy's
effect on measured oral health outcomes. The primary goal of this K08 application is to advance the
candidate's (Dr. Naavaal) research career by protecting her time to acquire training in health policy,
econometrics, and data science and gain research experience in applying these methods to conduct rigorous
oral health services and health policy research. This goal will be accomplished through executing proposed
research supported by carefully planned training objectives and intensive career development activities. The
proposed research outcomes will generate the evidence needed to inform strategies to strengthen existing and
new policies, including systems-level changes needed to minimize disparities and maximize oral health gains.
The expertise and guidance of the multi-disciplinary mentoring and advisory teams, in addition to the wealth of
resources and commitment to training provided through the institutional environment, will ensure the success
of the candidate's research project and enable her to establish a robust research program as an independent
research investigator.

Public health relevance
Narrative To improve oral health and reduce health inequities, it is essential to address structural barriers that impede access and use of dental services; on July 1, 2021, the Virginia Medicaid program expanded dental benefits, enabling 800,000+ adults to access comprehensive dental services. The research plan of this career development award aims to evaluate the multi-level impact of this large-scale dental policy change on access and use of dental care among adults and children and isolate the role of dental policy in addressing oral health disparities using advanced data science approaches. The resulting findings from this work will fill critical research gaps, generate actionable evidence to strengthen existing and new policies, inform programmatic decisions to improve oral health equity and support NIDCR's strategic goal of advancing oral health for all.